THE USE OF TRANSCRIPTIONAL FACTORS AS TARGETS AND AGENTS FOR CHEMOPREVENTION

Transcription factors are critical regulators of gene expression. It is cl r that these factors control the expression of many genes and as such mediate the biologic effects of agents such as "tumor promoters." The purpose of this project is to design mutants of transcription factors specifically aimed at inhibiting their biochemical and, most importantly, their biologic functions. The AP-1 complex has been specifically implicated in mediating the biologic effects of the tumor promoters "phorbol esters." A major component of this complex is the c-jun oncogene. We have created and tested a series of dominant-negative mutants of c-jun that are able to inhibit the biochemical functions of this oncogene. A transactivation mutant with a deletion of the N-terminal amino acids 2-122 has been shown to inhibit AP-I transactivation and c-jun transformation. In addition, this mutant has been shown to inhibit cellular transformation by a wide range of oncogenes including c-fos, c-raf, ras, mos, and myc. Further, stable expression of this mutant protein in mouse epidermal cells can block phorbol ester induced tumor promotion, and high level expression of this protein can inhibit signal transduction from a wide variety of growth factors. The mechanism of action of this mutant has been demonstrated to be heterodimerization with and neutralization of other AP-1 complex components such as c-fos. Our most recent efforts are aimed at further refining the potency and specificity of these mutants by creating smaller mutants with higher affinities for dimerization and DNA binding and testing them in specific human tumor systems such as breast and lung cancers. We have now created a series of c-jun mutants containing larger N-terminal deletions producing small peptides containing only the leucine zipper (dimerization domain). In addition, the potency of three DNA binding mutants (one with a point mutation at position 265, one with a deletion at positions 269-272, and one with an insertion of 3 amino acids at position 265) have been analyzed, and the mechanisms of action are presently being investigated. Future efforts are aimed at designing delivery mechanisms that might make these agents more clinically applicable. In vivo testing will be performed in model systems using transgenic technology and rodent model systems. Finally, we will expand these studies to include other transcription factors which play critical roles in human carcinogens such as CREB.